Regulation of Cell Death in HIV Reservoirs

ABSTRACT:
The combinational antiretroviral therapy is effective in suppressing HIV-1 replication. However,
latent HIV reservoirs cannot be cleared by such antiretroviral therapy, as viral rebound develops
rapidly after the treatment is interrupted in people living with HIV. The shock-and-kill approach to
eliminate HIV-1 reservoirs is to induce viral reactivation using latency reversal agents and trigger
cell death through virus-mediated cytopathic effects or immune-mediated clearance. However,
shock-and-kill by latency reversal agents has not been shown to successfully reduce the viral
reservoirs in HIV-1 patients. It has been reported that latency reversal agents can up-regulate
pro-survival autophagy and anti-apoptotic molecules that counteract cell death signaling.
Inhibition of these pro-survival mechanisms can promote the killing of HIV-1-infected cells, and
facilitate the killing of HIV-1 reservoir cells during vial re-activation. Experiments are proposed to
test hypothesis that cellular mechanisms that maintain the long-term persistence of HIV-1
reservoirs are important for protecting the reservoir cells against cell death, and targeting these
cellular mechanisms can sensitize HIV-1 reservoirs to cell death during viral reactivation: 1) To
determine the mechanisms for the specific induction of cell death in HIV-1 reservoirs in response
to viral reactivation. The mechanisms for the induction of apoptosis and alternative cell death
pathways in latent HIV-infected T cells by latency reversal agents will be tested; 2) To delineate
the mechanisms that confer the resistance to cell death in HIV-1 reservoirs upon viral reactivation;
and 3) To test whether targeting pro-survival mechanisms sensitizes HIV-1 reservoirs cells to cell
death during viral re-activation. The studies will reveal novel molecular pathways that could be
targeted to sensitize HIV-1 reservoirs to cell death, and facilitate the development of an effective
approach to clear HIV-1 reservoirs.

Public health relevance
NARRATIVE This study aims to characterize the mechanisms underlying the specific induction of programmed cell death in HIV-1 reservoirs, and to identify the mechanisms counteracting cell death that could be targeted to improve the clearance of the HIV reservoirs.